Next Generation KUH Researchers (GENERATOR) Training Core

The GENERATOR (“Next Generation of KUH Researchers”) is a research and career building program focused on predoctoral and postdoctoral scholars in KUH research laboratories. The training program will complement and fully integrate resources at the Mayo Clinic of Rochester (MCR) and the University of Wisconsin-Madison (UWM) as well as resources available through the U24 Interactions Core known as “Collaborating for the Advancement of Interdisciplinary Research in Benign Urology (CAIRIBU; housed at UWM). GENERATOR will leverage expertise from CAIRIBU to develop analogous career development activities for our “K” an “H” trainees. The primary goal or GENERATOR is to create a complete training pipeline and community of KUH researchers, spanning high school, undergraduate, post-baccalaureate, DVM and MDs in training, graduate, postdoctoral, and early career faculty levels. The five Specific Aims are: 1) Construct a pipeline that integrates investigators at multiple levels spanning high school through early career faculty into the KUH research space; 2) Recruit, select and maintain a trainee pool in KUH foci through continued evaluation; 3) Recruit, select and maintain a faculty pool in KUH foci through continued evaluation; 4) Develop and implement an engaging curriculum to provide fundamental training in KUH diseases, responsible conduct in research, grant writing, and professional development; 5) Integrate, organize, and offer existing resources (MCR, UWM) in a personalized training plan. We are committed to building, maintaining, and nourishing the KUH training pipeline and improving communication, collaboration, and teaching across this pipeline for upcoming generators of students, fellows, and early career faculty.

Public health relevance
We will recruit trainees into laboratories of KUH focused investigators, deliver a proven curriculum, oversee mentored research, promote individualized career-planning and integrate trainees with others ranging from high school to junior faculty. .